A Sequential Multiple Assignment Randomized Trial of Diet Treatments for Hepatic Steatosis and Cardiometabolic Risk in Adolescents

PROJECT SUMMARY/ABSTRACT
This application is in response to NOT-HL-21-020: “NHLBI Announces Interest in Promoting
Cardiovascular and Cardiometabolic Health in Early Stages of the Lifecourse” and addresses gaps
delineated by both NHLBI and the American Heart Association (AHA). Major gaps exist in the treatment
of NAFLD (now called metabolic-dysfunction associated steatotic liver disease [MASLD]), which is an
independent risk factor for atherosclerotic cardiovascular disease (ASCVD). Most of the ~7 million youth
with MASLD will progress to ASCVD and in youth, even small increases in hepatic steatosis (HS) are
directly related to peripheral dyslipidemia. MASLD disproportionately affects youth with Hispanic or
Latino ancestry, and it is an exceptionally heterogeneous condition, with varying patterns of
cardiometabolic factors, progression, and therapeutic response. Our work has shown that a registered
dietician nutritionist provided very low-sugar diet improves hepatic steatosis, dyslipidemia, and insulin
resistance and normalizes amino acid concentrations in adolescents with MASLD; however, the response
is variable. Essential amino acids (EAA) provided as an oral supplement have also been shown to improve
hepatic steatosis and dyslipidemia, as well as decrease appetite in adolescents with hepatic steatosis,
however, the response was also heterogeneous. Based on this prior work, there is a clear need for
innovation, applying precision medicine principles to develop therapeutic sequences that combine or
switch treatments and optimize outcomes in disproportionately affected children. Our long-term goal is
to improve outcomes for youth-onset MASLD. The overall objective for this R61/R33 application is to
answer the scientific questions that underly the construction of an efficacious, precise adaptive
intervention strategy of a registered dietician-provided very low-sugar diet and EAA protein supplement
to improve hepatic steatosis and cardiometabolic risk factors in youth with MASLD. The rationale for
using a sequential, multiple-assignment randomized trial (SMART) is that a SMART efficiently tests
multiple scientific questions. This trial is a substantial innovation over a traditional double-blinded RCT
because it acknowledges and integrates the wide variation in phenotype in MASLD. The evidence
generated will yield an affordable, adaptable intervention that will be evaluated in a future large
multicenter trial.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease (MASLD) affects more than 7 million youth in the United States, substantially increases the risk of future atherosclerotic cardiovascular disease, and is a highly heterogeneous condition disparately affecting youth of Latino descent. Effective, precision treatments are needed that optimize outcomes across both the hepatic component and the systemic cardiometabolic components of MASLD, tailored for individual patients. This trial will efficiently generate the data to create a precise, adaptive, patient-centered intervention, improving outcomes for youth with hepatic steatosis and cardiometabolic disease and reducing health disparities.